Assessing the Impact of Cannabis Legalization on Adolescent Cannabis Use and Cannabis-Related Health Conditions

PROJECT SUMMARY/ABSTRACT
Adolescent cannabis use is increasingly recognized as an important public health problem with significant
adverse health consequences. Recreational cannabis legalization (RCL) has high potential to increase risk for
adolescent cannabis use and cannabis-related health conditions. However, the effects of RCL on adolescents
are unknown. With a highly representative sample of nearly 1 million adolescents (N=900,000) regularly
screened for cannabis use in Kaiser Permanente Northern California’s large integrated healthcare delivery
system from 2015 to 2023, this multi-method study will address the pressing public health questions of whether
and how California state RCL and heterogeneity of local regulatory schemes impact the risk of adolescent
cannabis use and cannabis-related health conditions. We will use a quasi-experimental interrupted time series
design to test whether adolescent cannabis use, cannabis-related health conditions (e.g., cannabis use
disorder, other substance use, respiratory symptoms, mental health problems, cannabis-related accidents,
acute cannabis intoxication, cannabinoid hyperemesis syndrome), and cannabis-related healthcare use (e.g.,
emergency department, addiction treatment) and rise post-RCL. We will also examine local RCL policies
(retailer bans or caps, product and advertising restrictions, taxes, health warnings) and use geographic
information systems methods to map retailer location (e.g., distance from home address to the closest retailer)
onto individual-level electronic health record data collected in clinical care to test whether the effects of RCL
are stronger among those who live in communities with less restrictive local policies, adjusting for pre-RCL
medical cannabis policies. We will conduct hypothesis-driven moderation analyses to identify sub-groups
whose risk for cannabis use and cannabis-related health conditions may be greatest following RCL. To gain
further clinical insight into our quantitative data and guide next steps, we will conduct focus groups with
adolescents and interviews with addiction medicine clinicians, pediatricians, and emergency department
physicians to gain insight into how RCL impacts adolescent cannabis use and addiction treatment need from
the perspective of both patients and providers. Together, results will have immediate public health and clinical
implications, providing urgently needed data to identify potentially actionable areas for future policy adaptations
and aid decision making for public health practices to reduce adolescent cannabis use and cannabis-related
harms.

Public health relevance
PUBLIC HEALTH RELEVANCE With a highly representative sample of nearly one million adolescents (N=900,000) regularly screened for cannabis use in Kaiser Permanente Northern California’s large integrated healthcare delivery system from 2015-2023, this multi-method study will test whether and how California state recreational cannabis legalization (RCL) and local policies (e.g., retailer bans or caps, product and advertising restrictions, taxes, health warnings) impact adolescent cannabis use and cannabis-related health conditions using a quasi-experimental interrupted time series design. Quantitative results will be complemented by post-RCL interviews with addiction medicine, pediatric, and emergency department clinicians and adolescent focus groups to gain insights into the clinical impacts of RCL on adolescents. Together, results will have immediate public health and clinical implications, providing urgently needed data to identify potentially actionable areas for future policy adaptations and aid decision making for public health practices to reduce adolescent cannabis-related harms.